Regulation of sensory TRP channels by phospholipids and G-proteins

The topic of the original funded grant proposal was phosphoinositide regulation of the heat- and capsaicin
sensitive TRPV1, and the cold- and menthol-sensitive TRPM8 channels. The current renewal proposal
continues to study phosphoinositide regulation of TRPV1, and addresses an important unsolved problem,
brought to light by a recent higher resolution structure in lipid nanodiscs, which found that the
capsaicin/vanilloid binding site is occupied by a phosphoinositide, and proposed that it stabilizes the channel in
the resting state, and vanilloids activate TRPV1 by replacing the lipid. PI(4,5)P2 and PI(4)P however are well
established positive cofactors/regulators of TRPV1, which is difficult to reconcile with this model. The exact
nature of the phosphoinositide lipid, however, is not well resolved in the structure. In Aim1 we will elucidate the
nature of the phosphoinositide in the vanilloid binding site, using the combination of computational modeling,
site directed mutagenesis, whole cell and excised patch electrophysiology and planar lipid bilayers. The
TRPM3 ion channel is expressed in Dorsal Root Ganglion (DRG) neurons; its genetic deletion in mice results
in altered sensitivity to noxious heat. TRPM3 is activated by heat, and chemical agonists, such as
Pregnenolone Sulphate (PregS) and CIM0216. We found that this channel requires phosphoinositides for
activity, and we also found that agonists of phospholipase C (PLC)-coupled receptors inhibit TRPM3. This
inhibition, however, was not alleviated by intracellular delivery of excess PI(4,5)P2, and was reduced by a
protein that binds the βγ subunits of heterotrimeric G-proteins (Gβγ sink). This finding points to the dominance
of Gβγ signaling over PLC activation in regulating TRPM3. Activation of Gi-coupled receptors that do not
activate PLC also robustly inhibited TRPM3 activity, and the effect was reduced by Gβγ sinks. Co-expression
of Gβγ in intact cells, and application of purified Gβγ to excised inside-out patches also inhibited TRPM3, and
we detected biochemical interaction between TRPM3 and Gβ by co-immunoprecipitation. These data suggest
that Gβγ subunits are direct negative regulators of TRPM3. We also found that activation of endogenous Gi-
coupled GABAB and opioid receptors inhibited PregS-induced Ca2+ signals in DRG neurons. In Aims 2 and 3,
we will test predictions of our model of TRPM3 regulation, and elucidate the molecular determinants of this
effect using a combination of molecular biology, patch clamp, planar lipid bilayer, skin-nerve electrophysiology,
fluorescence-based cellular imaging techniques, and animal behavior.

Public health relevance
Chronic pain is an unmet medical need; associated costs have been estimated in the United States at hundreds billions of dollars annually. Intense heat causes pain, and hypersensitivity to thermal stimuli is a major symptom in chronic pain. We study the molecular regulation of TRPV1 and TRPM3, two important noxious heat sensing ion channels, and our work has the potential to lead to better therapeutic strategies against pain.